Women's Health Study: Infrastructure support for cohort follow-up

This proposal seeks infrastructure support only for core functions to conduct 5 years of continued follow-up of
the Women's Health Study (WHS), under PAR-17-233. The WHS began in 1992 as a randomized trial testing
aspirin, beta-carotene, and vitamin E for prevention of cancer and cardiovascular disease (CVD) in 39,876
healthy women over age 45. Prior to randomization, 28,345 women (71%) provided a blood sample: all have
been assayed for a wide range of biomarkers; genome-wide association studies (GWAS) have been
completed on >25,000, and exome chip genotyping on >22,000. The trial ended in 2004, and 33,682 (or 89%
of surviving women were willing to be followed observationally. Women report via yearly questionnaires on a
wide range of exposures and endpoints; we confirm self-reported cancer and CVD endpoints with medical
records, and cause of death by medical records and/or death certificates. Device-assessed 7-day physical
activity and sedentary behavior has been collected on 17,708 women. The WHS is unique in having extensive
genetic data as well as objectively-assessed physical activity and sedentary behavior in such a large cohort.
Follow-up is excellent: after almost 24 years, morbidity follow-up is still 89.6%% and mortality follow-up is
virtually 100%. As the average age of living participants is 77.1 years, event rates are increasing substantially:
at the end of current funding (8/31/19), 7,769 confirmed cancers will have occurred; by the end of the proposed
funding cycle (8/31/24), 10,869 cancers will be confirmed. This will substantially increase WHS's ability to
address important cancer questions, including examination of site-specific cancers, rare cancers, and tumor-
specific characteristics. The WHS has actively shared data with internal and external researchers, resulting in
650 papers published, 106 funded grants using WHS data, and collaboration in 22 NCI Cohort Consortium
projects. Currently, none of the ancillary studies provides funding for ascertainment and validation of cancer
(and CVD) endpoints.
In the proposed funding period, we will continue the WHS infrastructure, including the follow-up and evaluation
of self-reported exposures and endpoints, and maintenance of the WHS biospecimen repository, to further
facilitate data sharing and collaboration. WHS is also committed to continuing to provide leadership in research
aims related to gene-based prediction of incident disease and gene-environment interactions; improved
assessments of physical activity and sedentary behavior to study associations with health outcomes, and
evaluation of long-term chemoprotection of low-dose aspirin. Independent funding will be sought over the next
period to address specific hypotheses in these areas. In the next 5 years, continued infrastructure support and
follow-up is crucial for maximizing the cost-effective use of this valuable large-scale cancer cohort of women
with a rich resource of already collected phenotypic and genetic data, particularly since many WHS findings
have been and can be directly translated to clinical and public health practice or formal recommendations.

Public health relevance
This proposal seeks support over the next 5 years for the infrastructure of the Women's Health Study, a large- scale cancer epidemiology cohort of 39,876 women followed since 1992. Data are available on a wide range of characteristics, chronic disease development, blood biomarkers, genetic information, and objectively measured physical activity and sedentary behavior. Continued follow-up is crucial for building on the enormous amount of data already collected in order to answer critical questions related to cancer.